The evolution of virulence in the fungal pathogen Histoplasma

ABSTRACT/PROJECT SUMMARY
Background: Histoplasma is a pathogenic fungus that causes life-threatening lung infections. About 500,000
people are exposed to Histoplasma each year in the United States, and over 60% of the US population has
been exposed to the fungus at some point in their life. We have shown that Histoplasma is composed of at
least five different species that vary considerably in the type and magnitude of disease they cause.
Broad, long-term objective: The proposed research will help us identify the genes that allow virulence to
emerge and spread, as well as develop a panel of isolates that once deep-sequenced can be used by the
community of medical mycologists to map any trait of interest in Histoplasma. The objective of this proposal is
to discover whether the genes responsible for differences in virulence among isolates are similar across
species.
Specific aims: Aim 1 of the study proposes to generate genetic reference panels for three species of the
human pathogen Histoplasma. We will use this resource to identify alleles involved with virulence differences
within and between species. Aim 2 will genetically test the phenotypic effects (i.e., virulence in vitro and in vivo)
of the genomic hypotheses produced in Aim1. Aim 3 will study the spread of alleles in clinical samples over a
period of 40 years and will integrate the results from Aims 1 and 2, allowing us to determine whether any of the
alleles involved in virulence have increased in frequency.
Method: This haploid organism is ideal for the laboratory study of fungal pathogens, and it is well-suited for
genomic analysis. We will generate genetic reference panels for three different species of Histoplasma with
state-of-the-art genomic tools and genome-wide association mapping. We will use this panel to identify the
genetic basis of virulence differences within isolates of the same species. Notably, we will generate an online
portal to analyze GWAS data, a first in the medical mycology community. Preliminary results show that given
the amount of phenotypic variance in virulence, our approach and proposed sample sizes make this project
feasible. Validation of candidate virulence genes will be undertaken according to established cell culture and
mouse infection assays. Our approach will generate tools and reference panels for the fungal genetics
community.
Health-relatedness: The disease burden caused by Histoplasma species is substantial in the United States,
with a conservative estimate of at least 3.4 cases per 100,000 population. If infectious strains can transmit the
ability to cause infection to less harmful strains through gene exchange, the potential future disease burden will
grow as global trade, travel and climate change bring new species of the fungus into overlapping geographic
regions. The proposed research will identify what loci are involved in the evolution of virulence and will study
the influence of natural selection in their evolution in recent timescales. This application is in response to a
recent NIH Funding Opportunity Announcement (PA-19-082) supporting research on histoplasmosis and two
other endemic fungal diseases, and this program specifically encourages submission of R01 applications that
will “expand understanding of speciation and impact on clinical outcome.”

Public health relevance
NARRATIVE The fungus Histoplasma causes lung infections in humans, and each year there are about 500,000 new infections, 5,000 people hospitalized, and 800 deaths due to histoplasmosis in the U.S alone. We have discovered that Histoplasma is composed of at least five species and that they differ in how they cause disease and the immune responses they trigger. Our proposal combines the power of population genetics with that of molecular genetics in Histoplasma to identify and understand the genetic basis of alleles involved in differentiation between Histoplasma species.